Improving the translational value of head and neck cancer patient-in-mouse models

Project Summary
Patient-derived model systems are commonly used to study tumor biology and test novel treatments for head
and neck cancer. Our goal is to improve the use of mammalian model systems of head and neck cancer to
improve treatment outcomes for patients using valid, predictive, well characterized models. The goal of this
supplement is to study cancer evolution and therapeutic response with rigorous assessment of tumor biology
and genomic alterations to understand how choices made at the time of establishing models impact their
relevance over time. Aim 1 will assess the role of heterotopic vs. orthotopic implantation on the therapeutic
response and biology of the tumor. Aim 2 will test the concordance of response between patient-derived
models and patients. We will use this supplement to support a minority graduate student in the medical physics
program to study the effect of radiation on tumor evolution, to provide her with additional training in team
science, mentoring, teaching, and communication to support her pursuit of an independent research career.

Public health relevance
Project Narrative When developing new cancer treatments, many scientists use animal models in which human tumors are implanted into research animals (i.e. patient-derived xenografts or PDXs). However, we lack understanding of how we bias our results based on the methods we use to make new PDXs (e.g. implanting tumor pieces under the skin of immunocompromised mice as opposed to implanting into the site of origin). To improve the efficiency of pre-clinical research, this proposal will provide a clear answer to this question in head and neck cancer by methodically studying the site of implant, and the age of the tumor, tumor biology, evolution, and response to radiation.